Admin Core

PROJECT SUMMARY
The central goal of this murine Tissue Mapping Center (TMC) is to produce single cell resolved, multi-modal,
and multiscale spatial maps of cellular senescence in murine brain, breast, colon, bone marrow and liver
throughout lifespan. The Administrative Core will be responsible for providing the administrative infrastructure
necessary for the operation of the Tissue Mapping Center to achieve this overall goal. The Administrative Core
will coordinate, evaluate, and provide operational oversight to all components of the research program through
actions such as: monitoring overall TMC progress, maintaining scientific rigor, making decisions on milestones
and deliverables, allocation of resources and research core effort, equipment acquisition and management,
ensuring that team members have requisite support and infrastructure maintained by their host institutions,
producing/generating staffing plans, and other policies. In particular, the Core will establish a leadership plan
and organizational structure centered around Administration Core Leaders, a Scientific Leadership Team, and a
Program Management Team. This structure will facilitate an open, adaptable, and collaborative cycle of
discovery and experimental design in support of reaching TMC milestones, as well as facilitate bi-directional
interactions with the greater SenNet consortia. The Administrative Core will, through its program management
team, coordinate research activities across research cores, including tissue collection, tissue preparation, cell
isolation, single-cell assays, spatial assays, data analysis, experimental validation, and interpretation of results
by leveraging project management tools and approaches as well as active interaction through regular team
meetings, leadership committee meetings, and an annual retreat. The Program Management Team will assess
milestone progress on a regular basis, providing reports to the Core Leaders and Scientific Leadership Team.
Lastly, the Administrative Core will provide support for the open communication and collaboration with the larger
SenNet, including SenNet leadership, NIH, Consortium Organization and Data Coordination Center (CODCC),
other SenNet research groups, etc. - as well as provide the underlying administrative infrastructure to ensure the
free exchange of data, resources, tools, and ideas. Throughout these activities, the core will ensure adherence
to network-wide policies and procedures.